Nutrition Obesity Research Center (NORC)

Project Summary – Overall Component
The overarching theme of the Nutrition Obesity Research Center (NORC) at the University of North Carolina at
Chapel Hill (UNC) is “Interdisciplinary Nutrition Research: From Molecules to Public Health.” The UNC NORC
brings together community, population-based, clinical, and basic science investigators to increase the
effectiveness of nutrition and obesity research. Truly innovative, high-impact research requires communication
and collaboration of researchers along the continuum from basic science through clinical to public health
research. To facilitate a bidirectional translational process, the UNC NORC created an infrastructure that
makes it easy for investigators from different disciplines, who often speak different scientific “languages,” to
share methods and ideas so they can solve problems relevant to nutrition and obesity using new perspectives
derived from the interfaces of their disciplines. We propose an Administrative Core and four biomedical
research cores: the Animal Metabolism Phenotyping Core, the Clinical and Community Human Assessment
and Interventions Core, the Metabolism and Metabolomics Core, and the Precision Nutrition Core are
successful cores providing exceptional services to both UNC NORC members and external users across the
nation. The UNC NORC Pilot and Feasibility Program successfully funds young investigators who were able to
use this seed money to develop competitive NIH proposals, and the Enrichment Program disseminates the
results of the UNC NORC’s members. Our record of success during the last funding period is substantial. The
UNC NORC has 136 member scientists from 39 different departments and divisions of UNC. They have
exceptional research funding, having been awarded $144.7 million in nutrition and obesity grant funding during
the last five years. Of this total, 88% was from federal grants ($127 million) with $29.2 million from the NIDDK.
Our research base members have an exceptional publication record, with 912 peer-reviewed publications that
are directly related to the support they received from the UNC NORC. Maintaining research cores across a
range of disciplines, the UNC NORC will continue to serve as an interdisciplinary research translation engine to
advance nutrition and obesity research.

Public health relevance
Project Narrative – Overall Component The Nutrition Obesity Research Center (NORC) at the University of North Carolina at Chapel Hill (UNC) takes as its central theme “Interdisciplinary Nutrition Research: From Molecules to Public Health.” We propose an Administrative Core and four biomedical research cores: the Animal Metabolism Phenotyping Core, the Clinical and Community Human Assessment and Interventions Core, the Metabolism and Metabolomics Core, and the Precision Nutrition Core. As an integrated whole, the UNC NORC will provide the framework, tools, and expertise investigators need to engage in the interdisciplinary research required to improve health outcomes.